STEROID METABOLISM IN TUMORS AND NORMAL TISSUES

Our model for the regulation of cholesterol biosynthesis is similar to general models for the action of steroid hormones. The model involves binding of an oxysterol metabolite to a specific binding protein. The sterol-protein complex formed then represses the synthesis of the regulatory enzyme in the pathway, 3-hydroxy-3-methlyglutary1-CoA (HMG-CoA) reductase. In support of this model, we have established the specificity of a cytosolic oxysterol binding protein for oxysterols that repress HMG-CoA reductase. Three different forms of the binding protein were detected: an unliganded form, Mr 236,000, which appears to be a trimer, a sterol-protein complex of Mr 169,000 which is a dimer, and a monmeric form of the complex, Mr 97,000. At acid pH (below 6.0), the protein undergoes a conformational change which greatly increases rates of sterol binding and dissociation and which allows the protein to bind nonspecifically to DNA. The binding protein has been partially purified (about 200-fold). We have identified two oxysterols, 24(S),25-epoxycholesterol and 25-hydroxycholesterol, in cultured fibroblasts and have demonstrated that both are produced in concentrations within the range that is required to regulate HMG-CoA reductase and sterol synthesis. 24(S),25-Epoxycholesterol arises via a branch in the pathway beginning with the formation of squalene 2,3;22,23-dioxide. We do not yet know the reactions that give rise to 25-hydroxycholesterol. Preliminary evidence indicates that the two oxysterols can be metabolized to more polar sterols which do not bind to the bnding protein. (D)